Transcriptional and epigenetic basis of lung epithelial cell fate

PROJECT SUMMARY
The lung epithelium consists of diverse cell types, as the result of embryonic progenitors undergoing a
series of precise cell fate decisions. Upon injury, a successful repair needs to restore the proper cell
fates. Recapitulation and modulation of in vivo cell fate biology holds promise for cell-based
regeneration therapy. Despite such fundamental importance and our accumulating knowledge of cell
fate regulators, the epigenetic basis of lung cell fate – defined in this proposal as chromatin state and
its relationship to transcription factor binding – is largely unknown, but essential for mechanistic
understanding of cell fate regulators. Combining mouse genetics, genomics of both purified bulk and
single cells, 3D imaging, and human stem cell technology, this proposal will test our central hypothesis
that sequential and combinatorial actions of NKX2-1 and Wnt signaling transcription factors control the
epigenetic maturation and maintenance of lung epithelial cell types in vivo. The proposal has the
following 3 aims. (1) To test whether lung fate maintenance shifts from Wnt-dependent to NKX2-1 self-
reinforcing as the lung matures. (2) To test whether NKX2-1 promotes AT1 versus AT2 cell fate as a
result of recruitment by YAP/TAZ/TEAD versus CEBPA, respectively. (3) To test whether NKX2-1
primes AT2 cells for AT1 differentiation.

Public health relevance
NARRATIVE The lung epithelium consists of diverse cell types, as the result of embryonic progenitors undergoing a series of precise cell fate decisions. Precise control of such biology ensures organism viability and vitality, while its recapitulation and modulation holds promise for therapeutic lung regeneration. Combining mouse genetics, genomics of both purified bulk and single cells, 3D imaging, and human stem cell technology, this proposal will tackle the interplay between the epigenome and its transcriptional regulators in lung epithelial cell fate determination, and represents a step toward our long term goal of integrating lung development and regeneration.